Regulatory clearance of a rehabilitation system for individuals with upper limb loss

ABSTRACT
Our work to date has resulted in the development of several technologies focused on improving the lives of
individuals with upper-limb loss (ULL). First, our Sense pattern recognition control system (and associated
Element low-profile surface EMG electrodes and FlexCell flexible lithium-polymer batteries) can interface with
most myoelectric hands, wrists, and elbows on the market. Second, our MyoTrain virtual-limb pre-prosthetic
training system has been demonstrated to help individuals with ULL learn to use pattern recognition. This system
is valuable in the “golden window” time period after amputation but before it is feasible to fit the patient with a
definitive prosthesis.
Based on our clinical experience, we identified three ways in which we could deepen our clinical impact,
particularly as related to the MyoTrain system. First, we noted that EMG classification accuracy could be
improved by decreasing intra-class scatter (improving repeatability) and/or increasing inter-class separation
(improving separability). How individuals incorporate these methods is user specific and they could benefit from
the incorporation of visual feedback – something that we call “Active Coaching”. Second, our business model
allows us to provide MyoTrain to the patient before reimbursement is available, which offers significant clinical
advantage. However, this currently still requires the prosthetist to fabricate a check socket for use with
each individual. We now propose to integrate a reusable wireless armband which would eliminate this issue.
Third, we plan to evaluate the efficacy of MyoTrain with a prospective trial of our technology suite and
associated clinical methodology. Specifically, we will test three hypotheses: 1) use of MyoTrain results in
skills transference to control of the final prosthesis; 2) the virtual outcome measures in MyoTrain are
correlated with real-world functional outcome measures; and 3) use of MyoTrain results in improved clinical
outcomes as measured by functional, subjective and usage metrics. The capstone of this project is the
submission of a 510(k) premarket notification application for the MyoTrain system.

Public health relevance
PROJECT NARRATIVE The mission of our company is to improve the lives of individuals with upper limb loss (ULL). In this project, we hope to empower the user by enabling improved control over their prosthesis. Specifically, this project is focused on a system to allow the user to start training for how to contract their residual muscles in order to generate signals which are sensed and interpreted by their prosthesis in order to drive the motors which control it. This is particularly important since currently there is not a system which is available to individuals before their prosthesis is fabricated, and this is the very time period in which training is the most valuable.